mGlide-Care: A mHealth Partnership with Care Givers to Improve HTN Management in Patients with Cognitive Impairment

Project Summary
The principal investigator Dr. Lakshmi’s goal is to develop evidence-based technology interventions that
support chronic disease care in older persons including those with mild cognitive impairment (MCI) and early
stage Alzheimer’s disease and Alzheimer’s Disease Related Dementia (AD/ADRD). This K24 application will
provide her with protected time to: 1) build skills in implementation science, aging research and the conduct of
research with persons with cognitive impairment and their family caregivers; 2) accelerate mentoring of early
career clinical faculty in the Department of Neurology particularly on K-awards and transition to the 1st R01; 3)
obtain pilot feasibility and effect size data for a larger clinical trial of a mobile health technology (mHealth)
intervention to improve hypertension (HTN) care in persons with MCI and early stage AD/ADRD. Dr. Lakshmi
is a tenured faculty in the Division of Epidemiology and Community Health, School of Public Health (SPH) at
the University of Minnesota and in the Department of Neurology. Her rich institutional environment includes
partnerships with the Divisions of Biostatistics and Health Policy and Management, Medical School
departments and community health systems. Dr. Lakshmi is a member of the Center for Health Aging and
Innovation, a collaboration that aims to advance interdisciplinary aging research. The research focus of this
K24 is improving the management of uncontrolled HTN in persons with MCI and early stage AD/ADRD. HTN is
the most significant stroke, cardiovascular disease and dementia risk factor and is substantially under-treated
especially in older persons. Dr. Lakshmi has worked on mHealth interventions since 2011, with a successful
record of multiple funded grants. Her clinical trial, mGlide RCT, is implementing a mHealth-based care model
for HTN care in community health systems serving diverse, low-income patients. In this K24, Dr. Lakshmi will
develop mGlide-Care – an adaptation of mGlide – to address uncontrolled HTN in people with MCI and early
AD/ADRD. Aim 1 will engage stakeholders to study the acceptability of mHealth mediated HTN care and will
use their input to develop mGlide-Care. Stakeholders are persons with early stage AD/ADRD and MCI, unpaid
family caregivers, primary care providers, geriatricians and clinical pharmacists. Aim 2 is a feasibility pilot to
test mGlide-Care vs. usual care in 75 participants with uncontrolled HTN and early stage AD/ADRD or MCI.
Caregivers will assist participants. Outcomes will include HTN control and participant and caregiver reported
measures. Dr. Lakshmi is the site-PI for two NIH research networks, StrokeNet and DISCOVERY
(Determinants of Incident Stroke Cognitive Outcomes and Vascular Effects on RecoverY). She also has
access to rich cohort data including Atherosclerosis Risk in Communities-Neurocognitive study (ARIC-NCS)
and others. Dr. Lakshmi will leverage the substantial resources from her health technology grants, StrokeNet,
DISCOVERY, and cohorts including ARIC-NCS to mentor junior investigators in NIA priority areas. Her goal is
to prepare her mentees for their own major scientific advances and independent research careers.

Public health relevance
PROJECT NARRATIVE Hypertension costs the U.S. about $131 billion annually. This research on technology-based care models to improve hypertension care in persons with early stage Alzheimer’s disease and Alzheimer’s Disease Related Dementia will prevent stroke and cardiovascular disease, reduce caregiver burden, and improve health equity.